Increasing the efficacy of non-activated CAR T cells by modulating IFN1 signaling

Chimeric antigen receptor (CAR) T cells have demonstrated their efficacy in treating blood-based cancers.
However, the durability of responses is often hindered by challenges related to long-term T cell persistence and
engraftment. The success of CAR T cell immunotherapy relies on the differentiation status and overall fitness of
the CAR T cell product. Current protocols involve the activation and ex vivo expansion of patient T cells, however,
activation leads to irreversible differentiation, compromising their therapeutic potency.
Our recent work showed that a manufacturing protocol utilizing non-activated T cells results in superior
differentiation characteristics and reduced exhaustion, with concordant benefits in long-term tumor control.
Nevertheless, as quiescent T cells are highly resistant to lentiviral infection, CAR T manufacturing yield is a
significant limitation with non-activated T cells. The goal of this study is to harness the intrinsic stemness qualities
of non-activated CAR T cells and improve their transduction efficiency and effector function, thereby enhancing
their durable efficacy following infusion.
Quiescent T cells initiate a type I interferon (IFN1)-mediated innate response upon lentiviral vector transduction,
which limits CAR T cell transduction efficiency. Our preliminary data indicate that pre-treatment of non-activated
T cells with an IFN1-binding protein enhances CAR T cell transduction efficiency, and promotes a more naïve
and central memory phenotype. This research will delve into the impact of IFN1 blockade on CAR lentivirus
transduction and function of non-activated T cells, both in vitro and in xenograft models in vivo. Given that
sustained type I IFN signaling facilitates tumor immune escape and resistance to therapies, we hypothesize that
continuous IFN1 blockade not only enhances T cell fitness by inhibiting the innate response to the lentiviral vector
but also amplifies the therapeutic efficacy of T cells in tumors reliant on IFN-mediated immune evasion. To
explore this further, we will evaluate the effect of sustained IFN1 blockade by constructing lentiviral transfer
plasmids encoding both a CAR and a secreted anti-IFN1 binding protein in various xenograft models of cancer.
Another key aspect of our investigation is the interplay between SAMHD1 and IFN1 signaling pathways in
quiescent T cells. SAMHD1 restricts nucleotide availability for reverse transcription and is upregulated by IFN1.
Given that Vpx, a component of natural HIV, degrades SAMHD1, we will assess the impact of Vpx incorporation
on the efficiency of reverse transcription and vector integration of CAR lentivirus in non-activated T cells. Our
hypothesis is that restoring Vpx, which targets rate-limiting steps of the viral transduction pathway,
will synergize
with IFN1 inhibition in quiescent T cells, ultimately enhancing lentiviral transduction efficiency and bolstering the
function in non-activated CAR T cells.
These studies represent a significant step toward enhancing T cell fitness by countering anti-viral defenses
triggered during manufacturing. We are dedicated to advancing the non-activated CAR T cell platform, with the
ultimate goal of improving the clinical potential of non-activated CAR T cells as a viable CAR therapy. Given our
well-established translational infrastructure, our findings hold immediate clinical relevance.

Public health relevance
Non-activated CAR T cells are a novel platform for T cell-based immunotherapies, generating enhanced potency and accessibility to more patients. We will explore mechanisms to further enhance the potency of non-activated T cells by inhibiting IFN1 which limits transduction and overall functional competence. We will also focus on restoring the expression of viral-associated proteins, and concurrently modulating the IFN1 response in quiescent T cells, to enhance transduction efficiency, which is a critical barrier to the use of these cells.